Enhancing State, Local, Tribal, Territorial Occupational Safety and Health Surveillance, Collaboration, Education, and Translation to Reduce Worker-Relation Injury and Ilness

Project Summary/Abstract
Work related injuries and illnesses are both common and costly, with approximately 2.6 million
work-related injuries and illnesses costing approximately $171billion per year. State, local, tribal
and territorial (SLTT)-based occupational safety and health (OSH) surveillance systems are
essential for identifying and preventing work-related injuries and illnesses. The Council of State
and Territorial Epidemiologists' (CSTE) proposed activities will enhance non-federal
jurisdictions' capacity to collect surveillance data across the 10 National Occupational Research
Agenda (NORA) sectors and all seven NORA cross-sectors for workers of all ages. Outcomes
will include a greater visibility of OSH issues, an increase in the workforce that is able to perform
the essential public health services related occupational health epidemiology, and for more
state, local, tribes and territories to have an effective occupational safety and health surveillance
program, and ultimately, a reduction in workplace exposures, injuries and illness for all NORA
sectors/cross-sectors. As the surveillance initiatives included in this proposal address all NORA
sectors, the outcomes outlined in the proposal support all seven of NORA's strategic goals as
well the NIOSH's intermediate goal for its surveillance program (SS 1.1). There are 24 outputs
in this proposal, however many of the outputs include multiple components so the total number
of outputs are appreciably greater. Examples of outputs include: Coordination between CSTE,
state, local, tribes, territories NIOSH and other partners; Reports, how-to guides and other tools
related to Occupational Health Indicators, which enable different jurisdictions to uniformly collect
and report on occupational health, illness and risk data; communication, training and outreach
strategies, such as webinars, newsletters and consultations to disseminate information and best
practices; working groups meetings and other forums for sharing scientific information; and the
development of OSH surveillance tools and technical documents. This proposal supports the
NIOSH Research to Practice (r2p) approach by fostering collaboration among non-federal
programs and NIOSH and providing a forum by which additional research needs are identified,
and by translating surveillance data through various communication and outreach strategies.
Additionally, the activities in this proposal will help educate the non-federal OSH surveillance
workforce, which will facilitate more partnerships in each jurisdiction to share research findings,
data, and educational messages for improvement of health and safety in workplaces across the
U.S.

Public health relevance
Project Narrative Occupational injuries and illnesses are significant public health problems, resulting in substantial human and economic costs. The initiatives outlined in this proposal by CSTE will enable state, local, tribal and territorial jurisdiction to increase their capacity to collect, analyze surveillance data on work-related injuries and illnesses across all NORA sectors and cross sectors. Enhanced surveillance systems will allow jurisdictions to more effectively identify and prevent work-related injuries and illness, thereby improving the health and safety in workplaces across the U.S.